Investigating intracellular cholesterol biosynthesis as a regulator of polycystic kidney disease progression

Project Summary/Abstract
Autosomal Dominant Polycystic Kidney Disease (ADPKD) is the leading genetic cause of kidney
disease, with an estimated economic burden of seven billion dollars annually. The only treatment
to slow disease progression has risk of severe side effects. Thus, there is significant need to
advance our knowledge of ADPKD pathogenesis to identify novel ways to slow cyst growth. We
have discovered that sterol regulatory element binding proteins (SREBPs) may attenuate cyst
growth. SREBP1/2 are the master transcriptional regulators of lipogenesis genes. Our preliminary
studies show that reducing SREBP1/2 activity accelerates cyst growth in mouse models of PKD.
Conversely activating SREBP1/2 signaling markedly slows cyst growth in mouse models of
ADPKD and prolongs survival. These results are unexpected, considering that higher fatty acid
(FA) synthesis or sphingolipids have been shown to aggravate PKD. However, in addition to lipids,
SREBP1/2 also enhance cholesterol synthesis with SREBP2 being preferentially active at loci of
genes in the cholesterol biosynthesis pathway. Indeed, we have discovered that cholesterol is
reduced in mouse and human kidneys with PKD. We have also found that reduction of only
Srebp2 also aggravates cyst growth, implicating the cholesterol pathway. Thus, while lipids such
as FA and sphingolipids are deleterious, cholesterol species may in fact be beneficial in ADPKD.
Based on these intriguing preliminary observations, we hypothesize that cholesterol plays a cyst-
attenuating role in ADPKD. We will test this hypothesis in the following specific aims: 1)Determine
if reducing intracellular cholesterol by inhibiting de novo synthesis or uptake aggravates ADPKD;
2) Determine if enhancing intracellular production of cholesterol slows ADPKD; 3) Identify
cholesterol client proteins in ADPKD. In summary our studies will advance our understanding of
metabolism in ADPKD and open new avenues of exploration for future therapeutic development
targeting the cholesterol pathway.

Public health relevance
Project Narrative Autosomal Dominant Polycystic Kidney Disease (ADPKD) is the leading hereditary cause of kidney failure and has limited treatment options. We will test whether enhancing intracellular cholesterol reduces PKD disease burden. These studies will provide new insights into understanding the pathogenesis of ADPKD and developing targeted therapeutics for a disease which has no cure.